Mitigating the statistical bias due to anatomical variation in pediatric fNIRS

Title: Mitigating the statistical bias due to anatomical variation in pediatric fNIRS
Abstract: Functional near-infrared spectroscopy (fNIRS) is a non-invasive neuroimaging method that records
changes in blood oxygenation in the brain using optical sensors placed on the scalp. Although this technique is
widely used for functional imaging, this approach does not provide any direct anatomical information about the
structure of the head, such as layer thicknesses and brain depth beneath the sensors. As a result, the
magnitude of fNIRS signals is confounded by variations in this unknown underlying anatomy which introduces
the potential for statistical bias when comparing across groups and in longitudinal studies. This is particularly
relevant for pediatric and developmental studies where this anatomy is expected to systematically vary across
sample groups. Currently in the fNIRS field, corrections for this unknown anatomy have been proposed using
semi-empirical formulas, look-up tables, or off-the-shelf statistical mediation models such as mixed-effects
modeling. However, these corrections are not able to account for the complexity of this problem and unable to
model heterogeneity across subjects and spatial locations. In this work, we propose to develop a statistical
correction method based on the construction of a database of distributions of these corrections across
demographics and spatial locations on the head obtained from analysis of existing pediatric anatomical MRI
data. We propose to use these distributions as priors in the analysis of fNIRS group level data to model bias
and uncertainty introduced by unknown anatomical structures.
Aim 1. Characterize how key anatomical and demographic factors influence fNIRS measurements.
Aim 2. Development and characterization of our proposed novel anatomical statistical distribution
model.
Aim 3. Integrate the proposed model into our existing open source fNIRS toolbox.

Public health relevance
Narrative: Functional near-infrared spectroscopy (fNIRS) is a popular neuroimaging method for pediatric brain imaging studies. However, since the sensitivity of fNIRS varies exponentially with the depth of the brain from the sensors placed on the scalp, it is impossible to distinguish between changes in the magnitude of evoked brain activity signals and changes in thicknesses of the extracerebral layers of the head or systematic variations in anatomy. This project introduces a novel analysis approach to use priors on the distribution of structural factors extracted from existing databases of structural MRI to incorporate marginal anatomical uncertainty per demographics as part of group level statistical tests for fNIRS in pediatric studies.